Culturally Responsive Academic and Career Trainings to Diversify the Biomedical Workforce

PROJECT SUMMARY/ABSTRACT:
Biomedical and Behavioral Science research education programs across the nation are faced
with challenges that must be collectively considered to meet the needs of the nation and drive
innovation. The challenges include a high number of PhDs being awarded relative to the
available academic faculty positions, student access to career and scientific leadership
development programs, and established programs to diversify a strong workforce. Here, we
propose specific initiatives that reduce barriers for students and postdoctoral fellows in STEM.
This project proposes to advance the academic and career progress of underrepresented
minority students and scientists in the Biomedical and Behavioral Sciences. SACNAS (the
Society for Advancement of Chicanos/Hispanics and Native Americans in Science), the largest
multicultural and multidisciplinary STEM diversity organization in the nation with a 46-­year
history, is ideally positioned to address these challenges. SACNAS will develop culturally
responsive academic and career trainings for its established network of underrepresented
minority students and postdoctoral fellows to enhance retention, increase workforce diversity
and facilitate progress along various career tracks (academia, industry, government, nonprofits)
within the Biomedical and Behavioral Sciences disciplines. The objectives are: 1) Complement
the home institute training of URM students to meet the nation’s biomedical research needs;;
2) Enhance the professional development and scientific leadership skills of the biomedical,
behavioral and clinical research workforce. The intended outcomes are: 1) full participation in
STEM research across all segments of the population including the URM community;;
2) preparing a supply of URM Biomedical researchers that better reflect the demographics of
the USA;; and 3) development of scientific leaders from diverse backgrounds. These objectives
will be met by accomplishing the following specific aims: Aim 1: Develop a Diverse Biomedical
Workforce Through Targeted Mentorship at the SACNAS National Conference and SACNAS
Chapters. Aim 2: Increase the Representation of Native Americans in the Biomedical Workforce
by Partnering with Institutions Serving Native American Students. Aim 3: Provide Professional
Development, Scientific Leadership and Career Transition Training to Postdoctoral Fellows.
These aims will address the national challenges in higher educational and addresses the need
to develop a diverse Biomedical and Behavioral workforce.

Public health relevance
NARRATIVE: Biomedical and Behavioral Science research education programs across the nation are faced with challenges (e.g. changing job markets), and potential opportunities (e.g. large diverse population), that must be collectively considered to meet the needs of the nation and drive innovations. SACNAS (the Society for Advancement of Chicanos/Hispanics and Native Americans in Science), the largest multicultural and multidisciplinary STEM diversity organization in the nation with a more than 46- year history, is ideally positioned to address these challenges. SACNAS will develop career trainings for its established network of underrepresented minority students and postdoctoral fellows to enhance retention, build leadership skill sets, increase workforce diversity, and facilitate progress along various career tracks (academia, industry, government, nonprofits) within the Biomedical and Behavioral Sciences disciplines.